Development, Maintenance, and Human-Specific Evolution of Cortical Circuits

ABSTRACT
Over the past two decades, my laboratory has focused on the identification of novel molecular and cellular
mechanisms underlying the development, maintenance (Project 1) and human-specific evolution (Project 2) of
cortical circuits. In Project 1, we propose to study the role of novel molecular effectors regulating the function of
the two most abundant organelles in neurons: the endoplasmic reticulum and mitochondria. We discovered that
these two organelles are morphologically and functionally very different in axons and dendrites. Even more
recently, we identified a novel tethering protein Pdzd8 mediating specialized contacts between these two
organelles. ER-mitochondria contacts (ERMCs) are emerging as unique biochemical and physiological signaling
platforms in most cells and we discovered that in dendrites of pyramidal neurons, ERMCs play critical roles in
regulating synaptically-evoked Ca2+ dynamics (Hirabayashi et al., Science 2017). We are now proposing to use
an array of new techniques to determine the role of Pdzd8-dependent ER-mitochondria coupling on dendritic
integration, synaptic plasticity and their impact on the emergence of feature selectivity in CA1 PNs.
Since 2010, we have also initiated a new paradigm to provide insights into one of the most challenging questions
in Neuroscience: ‘what makes the human brain unique?’. In particular, our work tackled whether or not the
uniqueness of the human cortical circuits has molecular and physiological determinants at the synaptic level. In
Project 2, we propose to continue the new paradigm we implemented starting to tackle this question, by studying
the role of human-specific gene duplications (HSGDs) as potential genetic modifiers of circuit development and
function. The first example of such an HSGD acting as a human-specific modifier of synaptic development and
cortical circuit architecture came from our study on SRGAP2A and its human-specific paralog SRGAP2C.
Humanization of SRGAP2C expression in mouse cortical pyramidal neurons phenocopies a partial loss of
function of SRGAP2A and leads to the emergence of phenotypic traits characterizing human cortical circuits,
protracted period of E and I synaptic maturation and increased density of both types of synapses. Our most
recent results demonstrate that SRGAP2C increases specifically the formation of cortico-cortical synapses onto
layer 2/3 PNs, increased reliability of sensory coding and improved behavioral performance in tasks involving
sensory discrimination (Schmidt et al. bioRxiv (2020); Nature in press). We propose to explore other aspects of
SRGAP2A functions and how humanization of SRGAP2C modulates them, including their role in microglial cells
where both are expressed and in synaptic plasticity within adult cortical circuits. We will also extend this paradigm
to other human-specific gene duplications as potential modifiers of cortical circuit development, limiting our scope
to 4 other genes expressed in maturing and adult postmitotic neurons in the mouse and human cortex. Our
projects will tackle with unprecedented relevance the relationship between genes, circuit architecture,
circuit function and behavior in the framework of human cortical circuit evolution.

Public health relevance
NARRATIVE Our Projects are focusing on (1) the identification of cellular and molecular effectors regulating the development of cortical circuits and (2) the discovery of human-specific genes and their functions during cortical circuit development and function. These projects will shed unique light onto what makes the human brain unique and both projects will improve significantly our understanding of cellular and molecular processes affected in socially devastating diseases such as neurodevelopmental disorders or neurodegenerative diseases.